Molecular Profiling (MP) Core G

SUMMARY/ABSTRACT: Molecular Profiling Core G
The goals of the Molecular Profiling Core (MP) Core G are to (a) perform the duties of the study-wide
biobank including tracking and distribution of samples to Project 3 and other Cores and Projects as needed,
(b) facilitate the rapid public sharing of biospecimens through NCRAD (National Centralized Repository for
Alzheimer’s Disease and Related Dementias) by providing them with twice yearly sample shipments for
deposition and administration to the general scientific community, (c) generate molecular data for
biospecimens collected from Projects 1 and 2, (d) provide iterative re-analysis of genomic data (RNA and
DNA) as necessitated by the activities of Project 4 to ensure that all study data is up-to-date with regards to
their respective analytical and annotation pipelines, and (e) provide expert consultation on all aspects of
biomarker discovery and development to the Precision Aging Network (PAN) investigators.
Project 1 biospecimens will consist of 10,000 dried blood spot cards (DBS). These DBS samples are self-
collected from the nationally distributed cohort of individuals who participate in the MindCrowd-Expanded
(MC-Expanded) cohort. The MP Core will perform APOE and array-based genotyping on these specimens and
deposit the raw and processed data into the study data repository via the Data Science (DS) Core. These
data will be utilized by Project 1 investigators to identify genetic risk factors that are associated with, or that
modify, cognitive performance on the MC-Expanded test battery. Additionally, through the use of the genome-
wide array data, each participant will be assigned individualized polygenic risk score (PRS) pertaining to the
various risk factors detailed in Project 2 (e.g., Alzheimer’s disease, hypertension, diabetes, sleep, etc.).
Project 2 biospecimens will consist of 1,620 plasma, serum, and CSF samples collected from the face-to-face
characterized cohort. Several molecular profiling datasets will be generated from these samples including;
whole genome sequencing, CSF biomarkers, immune and inflammatory measurements, pan-viral exposures,
T- and B-cell receptor repertoires, whole blood and cell-free exosome RNA sequencing, and Horvath
epigenetic clock determinations among others (detailed further in the MP Core). These data will be quality
controlled and uploaded to the study data repository in both raw and processed formats for use by
investigators in the Projects and Cores.
The acquired high-quality and wide-ranging molecular data will play significant roles in answering major
research questions in our proposed projects, and can also be used by the national research community
studying cognitive aging, Alzheimer’s disease (AD), and related dementias (ADRD).